Neural mechanisms of gas sensing in a human-infective worm

PROJECT SUMMARY
Skin-penetrating nematodes, including the human-parasitic threadworm Strongyloides stercoralis, infect over
one billion people worldwide and are a major source of morbidity in low-resource settings. Infections can cause
gastrointestinal distress, stunted growth and cognitive impairment in children, and even death in the case of
S. stercoralis infection. S. stercoralis infective larvae are developmentally arrested third-stage larvae that
navigate through the soil searching for hosts to infect. When they find a host, they infect by skin penetration,
resume growth and development inside the host in a process called activation, and navigate through the host
body to the small intestine. These parasites encounter widely varying levels of ambient oxygen (O2) and carbon
dioxide (CO2) throughout their life cycle, ranging from the near-atmospheric levels of O2 and CO2 they encounter
as infective larvae host seeking at the soil surface to the low O2/high CO2 levels they encounter as parasitic
adults residing in the human intestine. However, remarkably little is known about gas sensing in S. stercoralis or
any other mammalian-parasitic nematode. We propose to investigate the behavioral, neural, and molecular
mechanisms of gas sensing in S. stercoralis. We will conduct an in-depth, quantitative analysis of the behavioral
responses of S. stercoralis to acute changes in ambient O2 and CO2 levels as well as O2, CO2, and combined
O2/CO2 gradients using automated worm motility tracking. We will compare the responses of infective larvae,
activated infective larvae, free-living adults, and parasitic adults to changes in ambient O2 and CO2 to determine
how O2/CO2-evoked behaviors vary across life stages. We will then map and functionally characterize the neural
microcircuits that mediate behavioral responses to changes in ambient O2 and CO2. We will test the hypothesis
that the S. stercoralis homologs of sensory neurons and interneurons that mediate gas sensing in C. elegans
also mediate gas sensing in S. stercoralis but contain functional adaptations that enable parasite-specific
behavioral responses. Finally, we will identify and characterize the O2 and CO2 receptors that are required for
gas sensing in S. stercoralis. Together, our results will provide insight into how skin-penetrating nematodes use
gas sensing to find and infect human hosts. In the long-term, our results may identify new molecular targets that
could inform the design of novel anthelmintic drugs.

Public health relevance
PROJECT NARRATIVE Skin-penetrating parasitic nematodes infect over a billion people worldwide and are a major cause of morbidity in low-resource settings. This grant will investigate the behavioral, neural, and molecular mechanisms of gas sensing in the skin-penetrating human parasite Strongyloides stercoralis. Our results will address how these parasites use gas sensing to find and infect humans, which may inform the design of novel anthelmintics.